Photocleavable Mass-Tags for Spatial Multiomics of Alzheimer’s Brain Tissue

Summary/Abstract
Alzheimer's Disease (AD) is a chronic neurodegenerative disorder characterized by progressively worsening
dementia. AD currently affects over 6.2 million persons in the U.S. and approximately 30 million world-wide with
70% over the age of 65. The total public health cost of AD is expected to reach over $20 trillion by 2050. Despite
extensive efforts to develop AD therapies including small molecules, monoclonal antibodies and peptide-based
drugs, only aducanumab, whose efficacy is in doubt, has been approved by the FDA since 2004. A major challenge
is elucidating the molecular pathology involved in AD in order to develop effective early diagnostics and drugs.
While amyloid plaque formation due to aggregation of different Aβ-peptides has been an important focus, a myriad
of other molecules including tau, neuronal and glial receptors, endosomal-lysosomal related proteins, glycans,
phospholipids, cholesterol and metabolites have also been implicated in AD pathology. In order to obtain a detailed
understanding of the possible role of these diverse molecular species as well as the molecular targeting of candidate
drugs, there is an urgent need to develop sufficiently powerful, highly multiplexed and multiomic tissue imaging
techniques that can map at cellular resolution the 2D-spatial distribution and association of these diverse, AD
molecular players. The proposed Phase II project seeks to address this challenge by applying a new highly-
multiplexed, targeted method termed mass spectrometric imaging immunohistochemistry (MSI-IHC™). MSI-
IHC™ is based on the use of novel photocleavable mass-tags (PC-MTs) developed by AmberGen which when linked
to antibody or lectin probes enable targeted biomolecules to be identified in the mass spectrometric image. This
approach significantly exceeds the multiplex capability of fluorescence immunohistochemistry (IHC) and previous
cleavable mass-tag based methods which are generally limited to 5 biomarkers or require extensive cycling
procedures in the case of fluorescence. In addition, the ability to combine MSI-IHC™ with label-free, untargeted
small molecule mass spectrometric imaging (MSI) as well as fluorescence IHC imaging, on the same sample, greatly
extends its power. This is possible using unique double-labeled fluorescent-PC-MT probes and performing 2 rounds
of MSI. Together, these innovations can provide a much more comprehensive multiomic picture of the role of
various molecules in AD pathology. In Phase I, we have demonstrated the feasibility of this approach on mouse and
human brain tissue specimens including the ability to image simultaneously a variety of AD related molecules. In
Phase II we will build on this progress by applying MSI-IHC™ to human and transgenic AD mouse brain tissue
obtained from collaborators and commercial sources. One goal, in collaboration with Prof. R.A. Nixon at NYU, a
leading AD researcher, will be to investigate the role of neuronal endosomal dysfunction, the earliest known
pathobiology specific to AD. Image analysis with be performed using novel statistical physics and AI methods
previously developed for AD tissue and brain imaging.

Public health relevance
Narrative Alzheimer's Disease (AD) kills more people in the U.S. every year than breast and prostate cancers combined. A major challenge is elucidating the molecular processes involved in AD pathology and to develop drugs that can delay or block these processes. The Phase II project will evaluate a new spatial multiomics approach developed by AmberGen based on novel photocleavable mass-tags and mass spectrometric imaging. This approach enables the multiomic mapping at cellular resolution of AD brain tissue to reveal the spatial distribution and association of hundreds of key molecules suspected to play a role in AD pathology including polypeptides, proteins, lipids, glycans and metabolites as well as AD targeted drug candidates.